Leveraging large language models and knowledge graphs on clinical, pathological, and sequencing data to inform precision cancer therapy

Project Summary:
Precision medicine and targeted therapy are emerging domains in cancer biology that aim to incorporate
individual-level clinical, pathological and genomic profiles to tailor treatment strategies for cancer patients.
Several precision oncology knowledge bases, like OncoKB, My Cancer Genome, have been established to
democratize clinical decision-making by leveraging expert curation of biological and clinical significance of
alterations using publicly available resources. These knowledge bases, while extremely powerful, have their
limitations, including the scope of annotated genes and alterations, as well as identifying precise therapies for
specific combinations of a patient's genomic and clinical profiles. In this proposal, we plan to develop new
computational methodologies that will integrate (i) the broad range of implicit cancer knowledge accrued
by Large Language Models (LLMs) with (ii) the explicit structured clinical, pathological, and genomic
knowledge derived from cancer patients in the Memorial Sloan Kettering Cancer Center’s (MSKCC)
Clinical Sequencing cohort and AACR Project GENIE cohort. This will further be reinforced by expert
curation, with the aim to predict combinations of genomic alterations and clinical or pathological profiles
that can be matched to a specific cancer therapy. The goal of this research is to develop computational
models fundamentally anchored around knowledge graphs and LLMs to bridge the gap between clinical and
functional risk factors of cancer and cancer therapeutics, and to inform and enhance personalized therapies.
The first aim of this proposal is to develop a knowledge graph, MSK-CancerKG, based on patient-specific clinical,
pathological, and genomic alteration information from more than 100,000 patients from the MSKCC Clinical
Sequencing Cohort and the AACR GENIE Project cohort. This multi-relational knowledge graph will integrate a
wide spectrum of clinical features associated with each patient, abstracted features from pathological reports
corresponding to the patient-derived tumor samples, along with comprehensive characterization of genomic
alterations and the implicated genes. The second aim will be geared towards the fine-tuning of pre-trained Large
Language Models (LLMs) using the structured, detailed and more reliable cancer-specific knowledge from MSK-
CancerKG. We will meticulously benchmark these fine-tuned models against 4 state-of-the art pre-trained
language models, ultimately deriving an optimized combined predictive model, coined MSK-CancerLLM. The
benchmarking step will include successful clinical, alteration and treatment prediction accuracy on held-out
patient data. The third aim of the proposal will be to further fine-tune MSK-CancerLLM using clinical practice
guidelines and feedback to model output from cancer domain experts. The resulting model will be integrated into
an AI chatbot, called MSK-Assistant, to facilitate seamless integration and interaction between the backend
model and a frontend chatbot interface. Like the ChatGPT application, this will allow the research community to
query about cancer biology and personalized drug recommendations and therapeutic interventions.

Public health relevance
Project Narrative Most cancers are driven by an intricate interplay of oncogenic driver somatic mutations in risk-associated genes and patient-specific clinical characteristics often influenced by environmental and behavioral traits. In order to prescribe a personalized cancer therapy, understanding the optimal combination of the risk factors, which includes clinical, pathological and genomic data from each patient, is paramount. The proposed research endeavors to develop a fine-tuned Large Language Model (LLM) to (1) supplement the structured cancer knowledge graph by integrating knowledge from both published text corpus and structured knowledge bases, and (2) predict drug or treatment to a patient based on the combined clinical sequencing and other patient-level clinical and pathological data; this fine-tuned model will be supported by an optimized chatbot to facilitate question-answering and reasoning.